Community Outreach Core

PROJECT SUMMARY
Community Outreach Core
TUFCCC Co-Leader: Yin Tan, MD, MPH HC Co-Leader: Ming-Chin Yeh, PhD
Evelyn Gonzalez, MA Marilyn A. Fraser, MD
Early detection for cancer screening has long been established as an effective tool to reducing the cancer
burden; however, utilization of these services by underserved racial and ethnic minorities (UREM) continues to
be disproportionate. For example, breast cancer (BC) and colorectal cancer (CRC) screening remains low
among African American (AA), Asian Pacific American (APA), and Hispanic American (HA) populations. These
pre-existing disparities were further exacerbated by the COVID-19 pandemic. Implementing culturally tailored
evidence-based cancer screening interventions to foster BC and CRC screening re-engagement through
community engagement and capacity building in underserved AA, APA, and HA communities is crucial. In
addition, up to 10% of all cancers may be caused by inherited genetic profiles. In recent days, genetic/genomic
testing for cancer risk assessment and treatment has been widely utilized clinically for cancer early detection,
diagnosis and treatment. However, the testing rates remain low in racial/ethnical minority populations as they
often face challenges and systemic barriers of social determinants of health, such as language barriers, low
health literacy, poor awareness and knowledge about genetic/genomic testing, and medical mistrust.
Overcoming these barriers to raise awareness and to increase testing is vital. Thus, building on the success of
our current funding cycle (2018-2023) in collaboration with TUFCCC/HC Partnership investigators and
community partners in the PA-NJ-New York City (PNN) region, the COC aims to use community-engaged
approach to addressing systemic barriers and promoting inclusion in accessing evidence-based
interventions on cancer screenings and genetic testing among underserved and understudied AA, APA and HA
populations. Specifically, the overall goals of the proposed COC are to: (1) engage the community in cancer
outreach and sustain cancer screening programs within the communities we serve, (2) support U54
investigators/ESIs/Trainees on community-based cancer research through building and maintaining sustainable
CBPR infrastructure; and (3) facilitate and enhance bi-directional communication between TUFCCC/HC
investigators and community.